Programable Modular Synthesis of Sulfated N-Glycans and O-Glycans

Project Summary
Sulfation is the most abundant and diverse glycan modification which tunes the physical properties and
biological activity of residing glycans and glycoproteins. Other than sulfated glycosaminoglycans (GAGs),
sulfation is also commonly identified on N-glycans and O-glycans but is often overlooked. These glycans are
believed to play critical roles in many physiological/pathological processes and glycan-protein interactions, the
first example of which was the discovery of sulfated glycan ligand (on both N-glycans and O-glycans) for L-
selectin in lymphocyte homing and recruitment. Many Siglec-glycan ligand interactions are also found to be
“sulfation dependent” or enhance by sulfation. Nevertheless, current knowledge of the structures and functions
of these sulfated glycans is still limited, and mainly concluded from genetic studies and the use of simple sulfated
glycan determinants, which may not be complete or accurate as underlying structures significantly affect glycan-
protein interactions. Despite the significance, systematic synthesis of sulfated N-glycans and O-glycans has
never been achieved, which represents a major obstacle in understanding glycan sulfation. A major challenge is
the great diversity which is derived from multiple branches and cores of N-glycans and O-glycans, as well as
many potential locations of sulfate groups on them. The presence of keratan sulfate chains on N-glycans and O-
glycans further expands the sulfated glycan repository. To completely solve this problem, we propose to develop
a chemoenzymatic modular synthesis platform, by integrating sulfation modules into our current modular
synthesis platform for non-sulfated N-glycans and O-glycans. Mammalian sulfotransferases will be expressed,
fully characterized in terms of activity and acceptor specificity, and used to construct efficient sulfation modules.
Optimized sulfation modules will then be combined with glycosylation modules to synthesize sulfated structures.
The modular synthetic process will be well-programmed based on the substrate specificity of involved enzymes.
A comprehensive library (300+) of sulfated N-glycan, O-glycan, and keratan sulfates will be prepared to
showcase the powerfulness of the modular synthesis platform. Multiple chemical or enzymatic modulations will
be introduced to achieve regio- and branch-selective sulfation. The resulting compounds are important standards
for glycomics analysis and probes to understand the functions of sulfated glycans as well as many biological
processes. The modular synthesis process is programmable and can be readily adopted for automated synthesis.

Public health relevance
Project Narrative Sulfation is the most common modification of carbohydrates yet is often overlooked. Effective and innovative methods will be developed and related enzymes will be expressed for facile synthesis of complex N- glycans and O-glycans with defined sulfation patterns. The resulting compounds are important standards for glycomics analysis and probes to understand the functions of sulfated glycans as well as many biological processes.